Mechanisms of STING in malignant progression and therapy of CLL.

Project Summary/Abstract
Chronic lymphocytic leukemia (CLL) represents 30% of adult leukemia and is still incurable. According to the
National Cancer Institute, approximately 21,250 new cases of CLL and 4,320 deaths from CLL are projected in
the United States alone in 2021. Although the Bruton's tyrosine kinase inhibitor (BTKi) is an effective targeted
therapy for CLL, approximately 50% of BTKi-treated CLL patients have dropped out of the therapy due to
chronic adverse effects. Additionally, significantly increased numbers of CLL patients treated with BTKi or other
kinase inhibitors have developed the more medically challenging diffuse large B cell lymphoma. Novel therapy
that can directly target CLL or be rationally combined with BTKi is highly desirable. The stimulator of interferon
genes (STING) is an endoplasmic reticulum (ER)-resident protein critical for sensing cytoplasmic DNA and
promoting production of type I interferons, thereby boosting immune responses. STING agonists, such as
ADU-S100, have been used as combination immunotherapy with Pembrolizumab in clinical trials to treat
advanced solid tumors and lymphomas, and these therapeutic applications of STING agonists are based on
the main known function of STING in eliciting anti-tumor immunity. We were the first to show that STING
agonists directly induce potent mitochondria-mediated apoptosis in B cell-derived malignancies including CLL,
while these agonists induce production of interferons in melanoma, hepatoma and lung cancer cells without
suppressing their growth. Apoptosis of CLL, B cell lymphoma and multiple myeloma requires STING, because
genetic deletion of STING results in resistance of all these cells to STING agonist-mediated apoptosis.
Apoptosis of these cells is not due to the production of inflammatory cytokines but may involve the prolonged
presence of agonist-bound STING. Together with our new preliminary results showing that mutation-mediated
activation of STING causes rapid degradation of the B cell receptor (BCR) and significantly reduced BCR
signaling (disadvantageous for CLL survival), and that novel serine residues on STING are phosphorylated in
agonist-stimulated malignant B cells, we propose to identify and characterize differential phosphorylation and
interacting partners of activated STING to further understand the mechanisms by which activated STING
causes BCR degradation and apoptosis in CLL. Since our preliminary data show that STING deficiency can
lead to increased levels of the BCR and BCR signaling in mouse CLL, and that mouse and human malignant
CLL cells significantly downregulate their expression levels of STING, we will test whether STING-
downregulated or STING-deficient CLL cells are less sensitive to BTKi. We will also examine how such altered
STING expression and phosphorylation can regulate the survival, progression and chemoresistance of CLL.
Based on our hypothesis that activation of STING can lead to the degradation of the BCR and render CLL cells
more sensitive to BTKi, we propose to combine STING agonists with BTKi to treat CLL.

Public health relevance
Project Narrative Our work suggests that activation of STING in chronic lymphocytic leukemia (CLL) cells is disadvantageous for their growth and survival. Further understanding the mechanisms of STING in regulating BCR degradation, apoptosis and chemoresistance in CLL will inform us of how STING agonists can be deployed as anti-CLL agents alone or in combination with inhibitors of the BCR signaling such as BTKi to treat CLL in the clinic.